Shared Resource-Bioinformatics Core

Bioinformatics Core Shared Resource - Project Summary/Abstract
The Bioinformatics Core provides analytical, computational, and technical services for all aspects of genomics
and bioinformatics research performed by Salk Cancer Center members. In the era of big data in biology,
bioinformatics analysis is crucial for deriving biological insights from large and noisy high-throughput data. The
goal of the Core has been to give Cancer Center members access to state-of-the-art bioinformatics expertise
and support. Staff in the Core assist Cancer Center members with integrative analysis of sequencing datasets,
provide software and tools that Cancer Center members can use to perform their own analyses, provide
training in software use, and develop customized tools and pipelines for cutting-edge analyses. The
Bioinformatics Core provides standard, best practice data analysis for commonly requested analyses such as:
variant calling from whole exome and whole genome sequencing data, annotation of genomic variants,
identification and annotation of peaks from ChIP-Seq, Clip-Seq, DamID, or 4C experiments, motif analysis from
these peaks, identification of differentially expressed genes from RNA-Seq and small RNA-Seq datasets,
identification and annotation of interactions from HiC datasets, identification of novel splice isoforms from RNA-
Seq datasets, reanalysis of published or generated microarray datasets, integration of diverse genomics
datasets (e.g., identifying correlations between differential ChIP-Seq and differential RNA-Seq datasets) and
pathway/overrepresentation analysis of analyzed genomic datasets. As needed, they also develop new tools
and techniques for Cancer Center members whose projects push the boundaries of research, generate
publication quality visualizations of analyses, and help prepare scientific manuscripts and grants containing
bioinformatics or genomics components.